Complement Protein C1q Regulation of Macrophage Metabolic Pathways

Complement Protein C1q Regulation of Macrophage Metabolic Pathways
PROJECT SUMMARY
Atherosclerosis is a chronic inflammatory disorder which in early stages is characterized by the migration of macrophages
and modified lipoproteins into the arterial walls, leading to the formation and apoptosis of macrophage foam cells. In late
stages of disease, insufficient apoptotic foam cell removal by macrophages leads to their secondary necrosis and plaque
development. Plaque damage by pro-inflammatory cytokines, proteases and oxygen radicals can lead to clinical
complications such as myocardial infarction and ischemic stroke. Thus, macrophage foam cell survival, cholesterol
removal, and inflammation are key factors in progression of this disease. Complement pathway activation by innate
immune protein C1q has been shown to promote disease progression. However, studies in C1q-deficient mice suggest a
protective role for C1q in the early atherosclerotic lesion. In addition to complement activation, C1q can directly opsonize
targets and interacts with phagocytes leading to increased phagocytic responses and reduced inflammatory cytokine
signaling. Macrophages can synthesize C1q and therefore C1q may be localized in macrophage-rich tissues, such as the
early atherosclerotic lesion, in the absence of other complement components needed for complement activation. Therefore,
our central hypothesis is that complement-independent actions of C1q program protective, anti-atherosclerotic
macrophage responses in atherosclerosis. Recent studies have identified a number of potentially beneficial mechanisms
of C1q on macrophage survival, efferocytosis, cholesterol metabolism, and inflammatory polarization in vitro and in vivo
models of atherosclerosis. The goal of this project is to investigate pathways and biological relevance of C1q modulation of
cholesterol metabolism, and to determine for the first time if there is a role for C1q in mitochondrial metabolism in
macrophage foam cells. Specific aims are: 1: Investigate C1q modulation of lipid metabolism in macrophages and
microglia. We will test the hypothesis that C1q modulation of LXR-activating lipids 24-OHC, 25-OHC, and desmosterol
are involved in macrophage foam cell survival, efferocytosis and polarization. Lipidomic analysis will be performed in
primary human M0, M1, or M2 polarized macrophage foam cells and murine microglia ±C1q. Survival, efferocytosis, and
polarization assays will be performed in specific pathway-deficient or knocked-down macrophages to identify their relative
importance in these biological responses. Specific Aim 2: Investigate C1q modulation of macrophage metabolic
programming. We will test the hypothesis that C1q modulation of mitochondrial metabolism and autophagy are involved
in macrophage foam cell survival, efferocytosis, and polarization. Changes to mitochondrial respiration, glycolysis and
superoxide production will be measured in human monocyte-derived macrophages during ingestion of oxLDL ±C1q.
Similar studies will be performed in murine bone marrow-derived macrophages from wild-type or C1q-deficient mice to
investigate autocrine vs. paracrine actions of C1q. Assays will be repeated in macrophages ingesting oxLDL ±C1q in the
presence of autophagy (or other metabolic pathway) inhibitors, or cultured in high glucose environment to identify
involvement of metabolic pathways in these biological responses. Overall, these studies aim to explore the dual role that
C1q plays in atherosclerosis, and should assist in identifying novel molecular pathways for therapeutic targeting.

Public health relevance
NARRATIVE This project aims to investigate the role of an innate immune protein, C1q in atherosclerosis / cardiovascular disease. C1q binds “bad cholesterol” and helps macrophage immune cells break it down to be removed from the body, which prevents dangerous plaque build-up. This project will focus on identifying the molecular mechanisms involved to identify novel therapeutic targets for treating atherosclerosis and improving public health.